Understanding the interplay of genetic and environmental contributions to human cell fitness

PROJECT SUMMARY
The behavior of all living cells is shaped by a complex and dynamic interplay of intrinsic and extrinsic factors.
However, despite a growing appreciation that metabolic conditions can impact the behavior of human cells, many
key knowledge gaps remain. One major difficulty is that conventional models have several limitations concerning
relevance to conditions in the human body and control of the extracellular environment. Therefore, it is a central
challenge to investigate fundamental human cell physiology and preclinical drug candidates in systems that more
closely model and address the impacts of cell-extrinsic factors. We previously created a new cell culture reagent
designed to simulate nutrient levels in human blood: Human Plasma-Like Medium (HPLM), thus pioneering the
systematic creation and use of synthetic physiologic media. Our results to date demonstrate that culture in HPLM
versus traditional media has widespread effects on cell metabolism, genetic dependencies, drug sensitivity, gene
expression, and immune cell biology. My lab also developed a chemostat system that enables the continuous
culture of human blood cells at metabolic steady-state under tightly controlled conditions. Our preliminary data
establishes that we can successfully maintain CRISPR screens, competition assays on mixed pools of over forty
DNA-barcoded cell lines, and primary T cell cultures in this new platform.
The high-level goal of my research program is to understand how metabolic conditions influence the behavior
of human cells, with an emphasis on elucidating genetic and environmental contributions to cell fitness. In pursuit
of this goal, our vision for the next five years will focus on three distinct areas that can be independently pursued:
1) understanding context-dependent genetic contributions to cell growth; 2) examining physiologic nutrient
dependencies; 3) delineating environmental contributions to T cell fitness. We will achieve our goals with a multi-
disciplinary strategy at the interface of engineering and biology, combining our innovative tools with approaches
from traditional molecular biology and biochemistry to state-of-the-art metabolomics, proteomics, and genome
editing. By deciphering cell-environment interactions with greater relevance, these studies will facilitate a deeper
mechanistic understanding of how various proteins and nutrients support cell fitness and why the importance of
such functions can also vary with context. This work will ultimately promote unique views of human (blood) cell
behavior with unprecedented levels of relevance and control over metabolic conditions that have been otherwise
inaccessible with traditional systems. In addition, this work promises to establish new paradigms for investigating
environmental contributions to cell biology and could transform the design and selection of models used for
studying human cells. Notably, unique mechanistic insights derived from our research could also lead to novel
therapeutic strategies for several disorders that hinge on cell growth or protective immunity, from cancer to
various infectious and autoimmune diseases.

Public health relevance
PROJECT NARRATIVE The behavior of living cells is shaped by a complex interplay of genetic and environmental factors, but our current understanding of human cell biology is largely derived from models that poorly reflect metabolic conditions faced in the body. We developed innovative tools and approaches that address this major limitation and are now using them to investigate cell-environment interactions with greater relevance to human physiology. This work will promote unique views of fundamental cell biology and inform novel therapeutic approaches for cancer, infectious diseases, and disorders of immunity.